Fostering Meaningful Use of Common Fund Data

To help ensure that Common Fund Data Ecosystem (CFDE) data assets, data tools, and resources are findable, accessible, interoperable, and reusable (FAIR), the project will create a CFDE Training Center (TC) responsive to the needs of biomedical researchers and current and future CFDE data programs. The TC will serve as the central hub for training development, coordination, and evaluation across CFDE programs and data initiatives.

Public health relevance
This project supports public health by enhancing the accessibility and usability of biomedical data through the creation of a Common Fund Data Ecosystem (CFDE) Training Center. By equipping researchers with the skills and resources needed to utilize complex datasets, the initiative fosters advancements in bioinformatics and data sciences that can drive innovation in medical research and public health solutions.